Risk and Geospatial Sciences Core

Risk and Geospatial Sciences Core (RGSC) ABSTRACT
The Texas A&M University Superfund Research Center is investigating the impacts of environmental
emergency-related contamination events across the source-to-outcome continuum, including exposure, human
health hazard, and mitigation of contamination and toxicity. In order to achieve the Texas A&M Superfund
Research Center’s ultimate goal of improving decision-making after an environmental emergency, the Center’s
Projects and Cores will need to make their findings interpretable to first responders, impacted communities, and
government bodies involved in site management and cleanup. Therefore, the entire Center will be supported by
a Risk and Geospatial Sciences Core (RGSC), which has expertise in synthesizing, mapping, and visualizing
relevant scientific data and conclusions for use by those involved in decisions related to risk management. The
overall objective of the Risk and Geospatial Sciences Core is to provide the Center with data and services for
characterizing human health risks and the geographic distribution from environmental mixtures created during
disasters, thereby supporting the cohesion, relevance, and implementation of project findings in the context of
environmental decision-making. Our work will facilitate interaction among Center projects, while also serving as
a bridge to the Disaster Research Response, Community Engagement, and Administration and Research
Translation Cores. Key services provided will include human health risk assessment (Aim 1), geospatial data
and analysis (Aim 2), and application to disaster research planning, sampling, and interpretation (Aim 3). In Aim
1, human health risk modeling will be used to make inferences about hazard or risk in the human population
based on experimental or observational data, serving as an essential bridge between scientific data and
environmental policy decisions. In the context of Superfund, human health risk modeling is used to demonstrate
that exposure standards or environmental remediation decisions both protect human health and reduce toxicity
or risk. In Aim 2, geospatial data and analysis will be utilized to address the complex spatiotemporal dynamics
of environmental emergency-related contamination, providing essential geographical contextualization and
visualization to inform decision-making. In Aim 3, the Core will provide both risk and geospatial expertise to
support rapid mobilization and sampling, as well as timely and decision-relevant interpretation, coordinated by
the Disaster Research Response Core. As a whole, these services will support the Center’s overall goal by
helping to interpret and translate research project findings into information that can be used by varied
stakeholders, from communities to federal and state decision-makers, to assess the human health impact of
contaminant exposures after an environmental emergency, and enhance the planning, emergency response, as
well as long-term recovery and remediation efforts related to environmental disasters.

Public health relevance
Risk and Geospatial Sciences Core (RGSC) NARRATIVE The Risk and Geospatial Sciences Core will support the Center in synthesizing, mapping, and visualizing relevant scientific data and conclusions for use by those involved in decisions related to risk management. These services will support the Center’s overall goal by helping to interpret and translate research project findings into information that can be used by varied stakeholders, from communities to federal and state decision-makers, to assess the human health impact of contaminant exposures after an environmental emergency, and enhance the planning, emergency response, as well as long-term recovery and remediation efforts related to environmental disasters.